Core C: Metabolic Phenotyping Core

Summary / Abstract
The objective of the current program is to further our understanding of the molecular mechanisms within the
brain that contribute to cardiometabolic control. The current core is designed to provide technical and
intellectual support for assessments of energy homeostasis in mouse models employed by all four projects
within the program. Through this core, projects will have access to an array of equipment used to assess
energy homeostasis including multiplexed systems (Promethion, OxyMax), NMR-based body composition
analyzers, bomb calorimeters, metabolic caging systems, respirometers, direct calorimeters, cellular
respiration systems, urinalysis/blood analysis systems, etc. In addition, core staff will provide surgical support
for all projects, and the PI will provide statistical support and training for all projects. The centralizing of these
endpoints into a core will support increased rigor and reproducibility of all metabolic phenotyping data across
the program.

Public health relevance
Project Narrative The objective of this core is to make available, centralize, optimize, and codify methods employed by all projects across the current program with regard to mouse metabolic phenotyping techniques. This core will provide technical and intellectual support to assess energy flux in mouse models, using methods including multiplexed phenotyping (Promethion, OxyMax) systems, NMR-based body composition, metabolic caging, bomb calorimetry, respirometry, direct calorimetry, and other methods. In addition this core will provide expert rodent surgical services and statistical analysis support services for all projects in the program.